Outreach, Recruitment and Engagement Core

PROJECT SUMMARY – Outreach Recruitment and Engagement Core (OREC)
Increased prevalence of dementia in African American and Hispanic communities compounds the
disproportionate economic and social burden that ADRD has in these historically under-represented groups,
thereby creating a public health crisis should these trends continue unabated. To innovate cures and
treatments, we need to understand the broadest characterization of AD phenotypes to enable discovery for
new biomarkers that index disease nosology and stage. UC Davis is a national leader for minority recruitment
and retention due to its commitment to the principles of Community-Based Participatory Research (CBPR).
Over its nearly 30-year history, the UC Davis ADRC has developed robust outreach and recruitment processes
that reliably identifies, efficiently screens, and clearly consents older adult participants from a wide range of
SES, educational and cultural backgrounds. We propose to enhance our continuing in-person efforts with a
complimentary digital e-toolbox. These e-tools use novel digital media marketing that allows us to match
unique participant demographics/interests (e.g., African American older adult without cognitive impairment
living alone in an urban setting) with specific content (e.g., a video vignette about coping with loneliness and
signs for when to see a doctor), thus enhancing participant engagement and creating a personally
meaningful recruitment experience. We refer to the combined toolbox of both in-person and e-resources as
the Memorable Outreach, Recruitment, Retention and Engagement (MORRE) toolbox. Using the enhanced
MORRE toolbox we aim to: (1) Outreach to diverse older adult communities of Black, Hispanic and White
older adults across Northern California; (2). Pique interest and call-to-action communities of color to participate
in a clinical research program focusing on Alzheimer’s disease and related dementias; (3) Retain our
participants in this clinical cohort by tailor making (a) appreciation events (in-person and digital) to focus on
how their personal contributions of time and effort make the difference in care and treatment discovery; (b)
easy-to-use health education media environment personalized to each participant’s age, education and
level/stage of disability in-person using familiar digital platforms (e.g., Facebook, YouTube, e-newsletters,
recommended content based on likes and viewing histories); and (4) Engage community leaders through our
community advisory board (CAB) in an ongoing dialogue about research project design, community principles
and priorities, potential facilitators and barriers that may impact recruitment, and strategize community-based
research project implementation. The significance of this OREC is its foundational support and advocacy for a
center-wide vision of CBPR though extensive collaboration with NIA, other ADRC cores and local community
partners. The scientific impact of the OREC will be its creation of sophisticated technical resources that
enhance recruitment, assessment and retention of Blacks and Hispanics into clinical research studies.